Function and Targeting of ETV6 in Ewing Sarcoma

PROJECT SUMMARY/ABSTRACT
Ewing sarcoma is a highly aggressive bone and soft tissue tumor mainly affecting children and young adults,
which still lacks effective therapy. Due to its low mutational burden, there are very few acquired vulnerabilities in
Ewing sarcoma cells. During my postdoctoral work, I discovered that transcription factor ETV6 is among the
very few top Ewing sarcoma-biased dependencies. Remarkably, although ubiquitously expressed, ETV6 is not
essential for cancer cells outside Ewing sarcoma, based on CRISPR screening efforts from us and others.
Genetic studies in mice also revealed that ETV6 is dispensable in the majority of tissues. Hence, perturbing
ETV6 function in Ewing sarcoma will have a wide therapeutic index. In the proposed project, I aim to further
study the detailed mechanisms of how ETV6 maintains the cancer cell state, and leverage this new knowledge
to develop therapies for Ewing sarcoma patients with exceptional potency and specificity. To do so, I will
characterize the mesenchymal differentiation phenotype of ETV6-deficient Ewing sarcoma cells using high-
throughput functional genomics and single cell transcriptomics. Integration of these `-omic' approaches allow me
to obtain a deep biochemical understanding of the cancer maintenance function of ETV6 (Aim 1). Moreover, I
showed that expression of the Sterile Alpha Motif (SAM) domain of ETV6, which is responsible for its self-
oligomerization, has a dominant-negative effect to endogenous ETV6, and inhibits sarcomagenesis in vivo.
Therefore, I propose to optimize this SAM peptide to increase its potency and further engineer it for exogenous
delivery (Aim 2). Successful generation of a potent, and tumor penetrating ETV6 blocker will benefit therapy
development. Finally, as transcription factors, like ETV6, have proven to be challenging targets for drug
development, I profiled for endogenous metabolites that can bind ETV6 to unveil druggable pockets, and
identified its association with phosphatidic acid. I will further explore the regulatory effects of phosphatidic acid
binding to ETV6 in Ewing sarcoma (Aim 3). Results from these studies will guide small molecule development,
and more importantly, will also reflect a novel mechanism for metabolic control of gene expression through direct
allosteric regulation of transcription factors.
During the mentored K99 phase, I will work closely with my mentor Dr. Christopher Vakoc and co-mentor Dr.
Carolyn Fein Levy, and collaborators Drs. Stegmaier, Kentsis, Shi and Furukawa, recognized experts in pediatric
oncology, peptide therapy, screening methodology and structural biology respectively. I have also established
an exceptional advisory committee at CSHL, constituted by Drs. Joshua-Tor and Beyaz, who will monitor and
support my transition to independence. In addition, CSHL will provide me an outstanding scientific environment
for my research and training, being a conference hub for world-renowned meetings and courses. My objective
is to obtain a faculty position to develop an impactful research program, where the K99/R00 funding mechanism
will serve as an essential step in my transition to independence.

Public health relevance
PROJECT NARRATIVE Ewing sarcoma is a cancerous bone tumor affecting children and young adults, which still lacks effective therapy and continues to be associated with high rates of mortality. Transcription factor ETV6 is a vulnerability in Ewing sarcoma cells while being largely dispensable in normal tissues, indicating a wide therapeutic index for perturbing ETV6 function in this disease. This proposal is dedicated to characterizing the cancer maintenance function of ETV6 and leveraging this new knowledge to develop beneficial therapies for Ewing sarcoma patients.